A Hybrid Implementation-Effectiveness Study of the Pharmacist, Physician, and Patient Navigator Collaborative Care Model to cure Hepatitis C among persons who use drugs with housing insecurity

ABSTRACT
Providing access to medications for persons with active substance use and housing insecurity is a remaining
challenge to achieving the national goal of HCV elimination by 2030. Our pharmacist-led collaborative care
model is designed to offer low-barrier syndemic care, including direct-acting antivirals (DAAs) for hepatitis C to
people who use drugs (PWUD) in the community. Through our prior NIDA grant (1R34DA047660), we
developed and pilot-tested the “Pharmacist, Physician, Patient Navigator Collaborative Care Model” (PPP-
CCM) approach for expanding access to DAAs. Guided by the RE-AIM framework, we will conduct a pragmatic
implementation trial using a parallel-group, cluster randomized design to evaluate PPP-CCM’s ability to
improve access to DAAs for HCV within a network of supportive housing units in Seattle and King County. We
will enroll 16 units, each housing 40-190 individuals, and randomize half of the units to receive point-of-care
(POC) HCV screening plus PPP-CCM versus POC HCV screening alone (control) for 12 months, after which
we will implement the intervention in control arm units as well. We will evaluate the implementation measures
based on RE-AIM (Reach, Adoption, Effectiveness and Maintenance) as well as other clinical outcomes and
substance use/HIV behaviors among the two arms. Additionally, we will conduct qualitative research to better
understand barriers and facilitators to implementation and maintenance which will inform the development of a
toolkit for dissemination to other supportive housing units throughout the state and country.

Public health relevance
PROJECT NARRATIVE Providing access to medications for persons who use drugs (PWUD) with housing insecurity is one of the last remaining challenges to achieving the national goals of hepatitis C elimination by 2030. The research proposed will implement the “Pharmacist, Physician, Patient Navigator Collaborative Care Model” (PPP-CCM) approach for expanding access to direct-acting antivirals (DAAs) for HCV and other potentially life-saving medications to PWUD. We will conduct a Hybrid Effectiveness-Implementation study using a parallel-group, cluster randomized controlled trial (RCT) of our intervention (PPP-CCM) to evaluate implementation success of PPP- CCM (reach, adoption, implementation, maintenance) and impact on treatment outcomes and substance use/HIV behaviors.